Lymphangiogenesis in chronic brain infection

PROJECT SUMMARY
Infections of the brain cause significant morbidity and mortality. During infections, the brain can swell in response
to direct damage by a pathogen and as a consequence of the immune response. The brain has a limited ability
to expand within the skull, leading to increases in intracranial pressure that can cause seizures, coma, or even
death due to brain herniation. In many tissues, lymphatic vessels remove excess fluid and immune cells to control
swelling and resolve inflammation. The presence of lymphatic vessels in the central nervous system was
described in 2015 and suggests that fluid and immune cells may exit the CNS via this meningeal lymphatic
network. In our studies examining the immune response to Toxoplasma gondii, a parasite that causes chronic
encephalitis in C57BL/6 mice, we find increased intracranial pressure and edema in the brain coincident with a
strong immune response to the parasite. Subsequently, we also observe that the meningeal lymphatics begin to
expand in length and complexity, consistent with lymphangiogenesis. The robust meningeal lymphangiogenesis
we observe is associated with a resolution of elevated intracranial pressure. We hypothesize that the expansion
of the lymphatic vessels allows for more fluid to leave the meninges which ameliorates elevated intracranial
pressure and for immune cells to exit the CNS reducing meningitis. We will test these hypotheses in two aims:
Aim 1. How does the blockade or promotion of meningeal lymphangiogenesis affect fluid homeostasis in the
infected brain? Aim 2. How is inflammation within the meninges affected by the expansion of the local lymphatic
vasculature? We will utilize two key tools to prevent and promote meningeal lymphangiogenesis. We will prevent
lymphatic growth by targeting the growth factors VEGF-C and VEGF-D using a soluble decoy receptor
(sVEGRF3) delivered to the meninges using an AAV. Conversely, we will treat mice with and AAV that expresses
VEGF-C to expand the CNS lymphatics to understand if enhanced lymphangiogenesis has a therapeutic effect.
We will measure fluid dynamics using tracer studies and measure any impact on tissue edema or intracranial
pressure. We will also examine how the immune response in the meninges and parasite burden are affected by
local the promotion or block of CNS lymphangiogenesis. Together these studies will examine how the newly
discovered meningeal lymphatic vessels function during CNS infection to maintain fluid homeostasis and control
inflammation. The induction of lymphangiogenesis in the meninges may have immense therapeutic potential as
there are limited interventions for chronic elevations in intracranial pressure due to persistent CNS infections.

Public health relevance
PROJECT NARRATIVE Infections of the brain can lead to serious consequences, including brain swelling and increased intracranial that can cause seizures, coma, and even death. In most tissues, lymphatic vessels are able to help remove excess fluid and immune cells to help resolve swelling and inflammation. Only very recently have lymphatic vessels been discovered surrounding the brain and we hypothesize that these lymphatic vessels expand during brain infection to help resolve brain swelling and limit the immune response.